Estradiol-mediated Gene Signatures in Hippocampal Memory

Project Summary
The sex-steroid hormone 17-estradiol (E2) has a well-established role in mediating neuronal physiology,
altering gene expression, and facilitating memory formation. Despite decades of research on E2’s
neuromodulatory effects, much remains unknown regarding which specific gene targets regulated by E2
contribute to its effects on neuronal function and memory. This is in part due to a lack of experimental feasibility,
as the tools necessary for examining cell-type specific transcriptional regulation by E2, and targeted manipulation
of specific E2-sensitive genes, were not previously available. Here, I propose to overcome these hurdles by using
single-nuclei RNA- and ATAC-sequencing, which will allow for comprehensive and unbiased identification of
gene targets regulated by E2 in both sexes at the single-cell level (Aim 1). This approach is advantageous to the
few existing studies examining transcriptomic regulation of sex-steroid hormones, which use brain homogenates
containing a variety of cell types for sequencing experiments. Although such work has been informative, the
receptors through which E2 orchestrates transcriptional control are expressed in a wide variety of distinct cell
types. As such, higher resolution approaches such 10X snRNA-seq and snATAC-seq at the individual cell level
will be necessary to understand the full myriad of estrogenic regulation of gene expression. Another limitation of
previous studies has been the inability to directly manipulate E2-sensitive gene targets to empirically test the
requirement of such changes in expression on memory formation. This proposal will overcome such limitations
by using cutting-edge CRISPR/dCas9-based epigenetic editing approaches to test the requirement of E2 action
at specific gene loci in mediating its beneficial mnemonic effects (Aim 2). Finally, although circulating levels of
E2 have been the focus of much neuroendocrinology research, E2 biosynthesis also occurs locally in the adult
brain of both sexes, via a process regulated by the enzyme aromatase (Cyp19a1). Aim 3 will use a
CRISPR/dCas9 approach to bidirectionally regulate aromatase expression specifically in neurons, to test the
role of neuron-specific E2 synthesis in memory formation. Collectively, these experiments will provide much
needed insight into how E2 acts as a key modulator of neuronal function and memory in both sexes.

Public health relevance
Project Narrative This proposal will provide insight into how the potent sex-steroid hormone 17-estradiol (E2) controls gene expression programs in a cell-type specific manner in the hippocampus, a brain region important for learning and memory whose function is compromised during aging and in certain mental health disorders. The proposed research is relevant to public health because it will improve our understanding of the neurobiological underpinnings that support healthy cognitive function, and inform the development of sex-specific therapeutic intervention strategies to treat neuropsychiatric disorders influenced by the hormonal milieu. Moreover, this work is particularly relevant to the NIMH’s first Strategic Objective (Strategy 1.1) which seeks to define cellular and molecular gene regulatory mechanisms relevant to cognitive function and mental health.